ACER2 in Chemotoxicity

Project Summary
Cancer is a major cause of deaths in both men and women in the U.S. and worldwide. Despite some advances
in targeted therapy and immunotherapy, traditional chemotherapy remains a major therapeutic modality for most
cancers, including breast cancer (BC). However, the efficacy of chemotherapy is limited due to severe
chemotoxicity, myelosuppression in particular. The specific goals of this application are to define a novel role
for alkaline ceramidase 2 (ACER2) in mediating chemotherapy-induced myelosuppression and to develop a
novel approach to targeting ACER2 for ameliorating this side effect. ACER2 is a member in the alkaline
ceramidase family that the PI’s group identified. ACER2 catalyzes the hydrolysis of ceramide to generate
sphingosine (SPH), a bioactive lipid implicated in both physiological and pathological programmed cell death
(PCD). Our published data demonstrated that ACER2 is a novel transcriptional target of p53 and plays a key
role in mediating PCD of human tumor cells in response to various DNA-damaging agents by accumulating SPH
in cells. Our preliminary studies now find that doxorubicin (DOX), a widely used chemotherapeutic agent, induces
PCD of human bone marrow hematopoietic stem/progenitor cells (HSPCs), which are responsible for sustaining
hematopoietic homeostasis and regeneration after injury, by upregulating the ACER2/SPH pathway. We further
reveal that knocking out the mouse alkaline ceramidase 2 gene (Acer2) protects mice from DOX-induced
myelosuppression by blocking the generation of SPH in the bone marrow. These compelling results support our
hypothesis that the ACER2/SPH pathway operates downstream of p53 to mediate chemotherapy-induced
myelosuppression (CIM). As a further corollary, we hypothesize that blocking the ACER2/SPH pathway will
mitigate CIM while improving overall survival in cancer patients who receive treatments with genotoxic
chemotherapeutic drugs, such as DOX. To test these hypotheses, we will 1) establish that the ACER2/SPH
pathway operates downstream of p53 to mediate chemotherapy-induced myelosuppression (Aim 1); 2) define
the molecular mechanism by which the ACER2/SPH pathway mediates chemotherapy-induced PCD of HSPCs
(Aim 2); and 3) Establish that targeting ACER2 with a small molecule inhibitor (AC2i) mitigates CIM while
improving antitumor efficacy of chemotherapy in a preclinical model of BC (Aim 3). Successful completion of
these aims will define the pathological role and mechanism of action of the ACER2/SPH pathway in
myelosuppression and other adverse events of chemotherapy and chemoresistance and may lead to novel
approaches to improving cancer therapy.

Public health relevance
Chemotherapy is a major therapeutic modality for advanced malignancies, a leading cause of deaths in the U.S. and worldwide. However, the efficacy of chemotherapy is limited due to severe side effects on normal tissues. This application is to achieve two major goals: 1) define a novel role for alkaline ceramidase 2 (ACER2) in mediating chemotherapy-induced myelosuppression, a serious adverse event that not only forces chemotherapeutic dose delays and reductions but also weakens the immune system in patients, thereby reducing the chemotherapeutic efficacy, and 2) to develop novel approaches to targeting ACER2 for ameliorating the toxic side-effects of chemotherapeutics while enhancing their antineoplastic activity.